Physical Frailty and Symptom Monitoring and Management Behaviors in Heart Failure (PRISM-HF)

PROJECT SUMMARY
While heart failure (HF) is the fastest growing cardiovascular condition in the U.S., about half of adults with HF
are also considered physically frail. In recent years, there is a better understanding of the intersection of physical
frailty with HF, including the strong association between physical frailty and worse patient-reported and clinical
outcomes in HF. Additionally, evidence shows that physical frailty affects women more than men in HF. However,
there is a lack of understanding of how physical frailty is associated with adverse outcomes, which hinders our
ability to develop and deploy effective biobehavioral interventions to mitigate these adverse outcomes. While
there has been work characterizing the biological profile of physical frailty in HF, the behavioral profile has not
been characterized from either a quantitative or qualitative perspective. One key behavior that adults with HF
must engage in is symptom monitoring and management (SMM). Monitoring for HF symptoms and engaging in
decision-making to address these symptoms (e.g. recognizing dyspnea on exertion and calling a provider) are
important behaviors that reduce adverse patient-reported and clinical outcomes. Physical frailty, however, may
impact SMM behaviors by blunting the monitoring of symptoms and hindering the management of symptoms,
resulting in adverse outcomes. Understanding the relationship of physical frailty with SMM behaviors may
characterize the behavioral profile of physically frail adults with HF, offer one possible explanation by which
physical frailty affects outcomes in HF, and provide a means of developing and deploying effective biobehavioral
interventions to address physical frailty in HF, our long-term goal. Therefore, the objectives of this exploratory
study are to 1) characterize the relationship between physical frailty, SMM behaviors, and outcomes, and 2)
identify SMM behaviors, aligned with the patient's perspective, to target with biobehavioral interventions. The
proposed study utilizes a sequential mixed methods approach wherein in Phase 1, we will collect cross-sectional
quantitative data from a sex-balanced sample of 120 adults with HF, and in Phase 2, we will collect qualitative
data from ~32-40 adults with the following aims: 1) quantify associations among physical frailty, SMM behaviors,
and outcomes in adults with HF; 2) describe the experience of SMM behaviors for physically frail and non-
physically frail adults with HF; and 3) identify the SMM behavioral needs of physically frail and non-physically
frail adults with HF. Accomplishing this state-of-the-art study is an important stepping stone towards the
development of larger proposals. Specifically, it will allow our team to merge our understanding of physical frailty
from a biological perspective with that of a behavioral perspective to develop biobehavioral interventions to
mitigate the adverse patient-reported and clinical outcomes associated with physical frailty in HF.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because about half of all adults with heart failure are also considered physically frail, which increases the risk of adverse clinical outcomes; but at the same time, we are limited in our ability to mitigate the adverse effects of physical frailty in heart failure. The results of this study will shed light on our understanding of the relationship between physical frailty, symptom monitoring and management behaviors, and outcomes in order to characterize the behavioral profile of physically frail adults with heart failure. The knowledge generated from this study will be used to develop personalized biobehavioral interventions for adults with heart failure.